Development of a Full Qualification Package for the PROMIS Short Form v1.0—Fatigue-Multiple Sclerosis 8a (DDT COA #000069)

ABSTRACT
Over 1 million people in the United States are living with multiple sclerosis (MS), and the majority
of people with MS are likely to experience severe, debilitating fatigue at some point. However, a
psychometrically sound, publicly available measure of fatigue severity optimized for persons with
MS from the patient perspective has not yet been recognized by FDA as fit-for-purpose for use in
drug development. We propose the preparation and submission of a Full Qualification Package
(FQP) to support the qualification of the PROMIS Short Form v1.0—Fatigue-Multiple Sclerosis 8a
(PROMIS FatigueMS—8a) as a patient-reported outcome (PRO) measure of fatigue severity in
individuals diagnosed with all forms of MS.
A measure of fatigue severity was accepted into the Center for Drug Evaluation and Research’s
(CDER’s) Clinical Outcome Assessment (COA) Qualification Program under DDT #000069 on
June 21, 2017. The PRO Consortium’s MS Working Group selected the PROMIS FatigueMS—
8a as the fatigue measure for qualification as it has been optimized for use in persons with MS.
At FDA’s request, an Initial Briefing Package was submitted on October 18, 2019, documenting
the development of and content validity evidence supporting the PROMIS FatigueMS—8a. Next,
a Qualification Plan (QP) was submitted to FDA on August 31, 2020; revised versions were
resubmitted on May 7, 2021, and November 15, 2021. The QP addressed the MS Working
Group’s research plan for obtaining the quantitative evidence to support qualification of the
measure. After FDA accepts the QP, the next steps will be to analyze cross-sectional and
longitudinal datasets to generate quantitative evidence and to prepare and submit an FQP.
Our approach includes 3 aims. For Aim 1, we will analyze available cross-sectional and
longitudinal datasets containing the PROMIS FatigueMS—8a in accordance with the accepted
QP and revised statistical analysis plan to document its validity, reliability, and responsiveness as
an outcome measure in people with all forms of MS. For Aim 2, we will prepare an FQP for the
PROMIS FatigueMS—8a using the CDER COA FQP content outline and integrate all evidence
supporting the measure, including results of the completed qualitative and quantitative research.
Aim 3 will involve the submission of the FQP with all necessary appendices and attachments,
including a user manual and the associated analytic datasets and programming code. The goal
of this project will be a publicly available and accessible PRO measure for assessing fatigue
severity in MS clinical trials for people with all forms of MS. As such, qualifying the PROMIS
FatigueMS—8a will fill a critical gap in the measurement of fatigue severity in MS treatment trials.

Public health relevance
NARRATIVE Over 1 million people in the United States are living with multiple sclerosis (MS), and the majority of them are likely to experience severe, debilitating fatigue at some point; hence, it is important that MS clinical trials measure fatigue and the impact of new MS treatments on fatigue severity. The overall objective of this project is to prepare and submit a Full Qualification Package to support the qualification of the PROMIS Short Form v1.0—Fatigue- Multiple Sclerosis 8a for use as a patient-reported measure of fatigue severity among individuals diagnosed with all forms of MS. The impact of this work will be the advancement of a publicly available, psychometrically sound measure of fatigue severity that can be used in MS treatment trials to effectively assess the impact of new drugs on severity of fatigue experienced by individuals with MS.